Controlling oscillations to treat Alzheimers disease targeting the basal forebrain parvalbuminsystem

Alzheimer's disease (AD) is a neurogenerative disorder characterized by early deposition of amyloid-beta
protein (Aβ) followed by tauopathy and impaired cognition. Innovative treatment strategies are needed. Recent
studies in amyloidosis and tauopathy model mice have shown that chronic 40Hz gamma entrainment using
sensory stimuli (GENUS) improves pathological and behavioral outcomes. However, these exciting studies
have not been independently replicated and optimal methods to reduce pathology by gamma entrainment are
unknown. Thus, here, we test whether optogenetic excitation of non-cholinergic basal forebrain parvalbumin
neurons (BF PV) enables widespread control of gamma oscillations throughout cortex and hippocampus to
treat amyloidosis/tauopathy and restore hippocampal-cortical oscillatory functions that support memory.
The mentored (K99) phase of this proposal will use 5XFAD mice to test benefits of 40Hz optogenetic BF
PV excitation in preventing amyloidosis. All experiments record ipsilateral local field potentials (LFP) in medial
prefrontal cortex (mPFC) and hippocampus (HPC). The first experiment directly compares the efficacy of 40Hz
BF PV excitation treatment against GENUS in reducing plaque pathology. The second experiment uses
chemogenetics to model pharmacologically targeting of BF PV and tests whether chemogenetic BF PV
excitation and GENUS synergize to improve outcome. The third experiment assesses the hypothesis that
chronic 40Hz BF PV excitation repairs gamma generating mechanisms in hippocampus and cortex to restore
oscillatory communication and rescue working memory. The fourth experiment will use a closed-loop
stimulation method to deliver two brief (10ms) laser pulses at the peak or trough of hippocampal theta phase to
assess whether theta-phase specific timing of BF PV excitation matters.
The independent (R00) phase studies will apply methods learned during the K99 phase to 3xTg
amyloidosis/tauopathy model mice to strengthen the case for BF PV targeted treatments of moderate to severe
AD. The same four experiments as above are proposed for these studies in 3xTg mice. Further, important
preclinical behavioral experiments will assess the hypothesis that BF PV excitation can be used to enhance
cognition in 3xTg mice without affecting motivation (a potential side effect) or reinforcement (abuse potential).
The training plan for this award includes mentorship from an expert team of Harvard Medical School
professors specializing in BF regulation of cortical oscillations and cognition. AD-directed training will be
provided by additional members of the mentorship team from Boston University and through the candidate's
participation in the Massachusetts AD Research Center Research Education Component program. The
proposed AD research and didactic activities and training on the study of neural oscillations will facilitate the
applicant's goal of becoming an independent investigator studying preclinical treatments for AD.

Public health relevance
This proposal provides scientific rationale and an empirical basis for targeting basal forebrain parvalbumin neurons (BF PV) to treat Alzheimer's disease (AD). This research will inform innovative treatment strategies by showing that BF PV excitation can be used to prevent the progression of AD pathology and restore hippocampal-cortical network integrity to rescue cognition.